TO SUPPORT AND IMPROVE THE INSTITUTE'S ABILITY TO PROVIDE ACCURATE, RELEVANT, AND UP-TO-DATE INFORMATION ON ITS PUBLIC WEBSITES.

TO SUPPORT AND IMPROVE THE INSTITUTE'S ABILITY TO PROVIDE ACCURATE, RELEVANT, AND UP-TO-DATE INFORMATION ON ITS PUBLIC WEBSITES.